Astrocytic regulation of prefrontal neural circuits and avoidance behavior

PROJECT SUMMARY
The major goals of neuroscience are to understand how the central nervous system (CNS) processes
information, generates emotions, stores memories, and drives behavior. Considerable effort has been devoted
to the study of neurons, yet neurons do not act alone in the brain. Thus, much is to be gained from understanding
the interplay between neurons and other non-neuronal cells, particularly glial cells. Astrocytes are the most
numerous glial cells and are present throughout the entire CNS. Their existence and close proximity to neurons
were recognized more than a century ago. However, our understanding of astrocytes is still in its infancy. Unlike
neurons, astrocytes do not transmit electrical action potentials, but instead utilize complex intracellular Ca2+
signaling to communicate with each other and mediate their effects on neurons and other cells. These astrocytic
Ca2+ signals occur throughout the entire cell, both spontaneously and in response to neuronal activity. Mounting
evidence has implicated astrocytic Ca2+ signaling as essential to modulating neuronal function and animal
behaviors. Importantly, abnormalities of astrocyte Ca2+ signaling are implicated in numerous neurological and
psychiatric disorders. However, despite progress, the physiological significance of astrocyte Ca2+-dependent
signaling for the function(s) of neural microcircuits in vivo, for animal behavior, and for brain diseases remains
incompletely understood. In this proposal, we aim to determine the roles of astrocyte Ca2+ signaling in regulating
the prefrontal neural circuit activity as well as avoidance behavior by addressing a series of fundamental
questions: What is the physiological relevance of astrocyte Ca2+ signaling from the medial prefrontal cortex
(mPFC) in avoidance behavior and does astrocyte Ca2+ signaling display subregional heterogeneity (Aim 1)?
Whether and how attenuated astrocyte Ca2+ signaling in the mPFC affect the prefrontal neuronal activity and
avoidance behavior (Aim 2)? Whether and how enhanced astrocyte Ca2+ signaling in the mPFC affect the
prefrontal neuronal activity and avoidance behavior (Aim 3)? Our proposed research will integrate state-of-the-
art techniques for genetic/chemogenetic manipulation of mPFC astrocytes and in vivo Ca2+ imaging of activity
dynamics of astrocytes and defined neuronal populations in freely-behaving mice to reveal the fundamental
mechanisms of astrocytes in mediating behavior. This investigation will yield novel, critical insights into the
intercellular communications between astrocytes and neurons. These insights will have a great potential to
inspire the development of new therapies to treat a wide range of brain disorders.

Public health relevance
PROJECT NARRATIVE As the most numerous non-neuronal cell types in the mammalian brain, astrocytes are proposed to regulate neuronal function via intracellular Ca2+-dependent signaling, which becomes deranged in numerous neurological and psychiatric disorders. The goal of this project is to elucidate the contribution of astrocyte Ca2+ signaling to the prefrontal neural circuit function and avoidance behavior. The proposed research is highly relevant to a broad range of mental disorders and may guide the development of innovative treatment.